Developing a P01 to Address Cognitive Impairment and Treatment Tolerability in Patients with Advanced Cancer

ABSTRACT
This application entitled “Developing a P01 to Address Cognitive Impairment and Treatment Tolerability in
Patients with Advanced Cancer” is being submitted in response to “Administrative supplements to advance
development of transdisciplinary and large-scale population science and cancer control research projects."
This application is led by 3 internationally renowned experts (Drs. Janelsins, Mohile, Mustian) in the fields of
cancer-related cognitive impairment (CRCI), tolerability, geriatric oncology, and exercise oncology, with over 75
collaborative publications. The goal of this supplement is to provide the resources for planning a successful
large-scale, synergistic program project application. People living with advanced cancer are unique and
different from patients treated for early-stage disease, as they often have complex medical trajectories and
treatment plans, leading to ongoing supportive care needs due to incurable disease. CRCI is one of the most
prevalent and burdensome complications, affecting many patients with advanced cancer. Our ultimate goal is
to submit a P01 application that addresses and intervenes on CRCI to improve treatment tolerability.
Specifically, our team plans to develop P01 projects to better understand the experience of CRCI in patients
with advanced cancer. Our team will also develop P01 projects to test novel exercise and diet interventions to
improve CRCI and treatment tolerability. This research aligns with NCI and Division of Cancer Control and
Population Science (DCCPS) priorities. Our proposed research specifically addresses NCI’s Notice of Special
Interest: Survivorship Research for People Living with Advanced and Metastatic Cancers (NOT-CA-25-024)
and PAR-23-059. This research also aligns with the priorities of Wilmot Cancer Institute, NCI’s newest
designated cancer center (P30CA272302). The MPIs have identified potential Project PIs; this team has been
meeting for the past two years to understand our multi-disciplinary expertise, brainstorm, and conduct initial
literature reviews and pilot studies. This supplement is perfectly timed to refine our P01 research projects,
synergy, and methods. Our supplement objectives include: 1) identify and finalize key research team members,
cores, and infrastructure, 2) conduct preliminary research to finalize an integrated biological model related to
CRCI and interventions, and 3) finalize an overarching theoretical framework, synergy, and research projects.
Key deliverables include finalized: 1) Project PIs/MPIs, 2) EAB members, 3) cores, 4) infrastructure
partnerships, 5) biological signatures and integrated model, 6) overall theoretical framework, 7) synergy map,
8) 3-4 research projects, 9) NCI pre-submission meeting, and 10) new preliminary data publications. We are
confident that we will meet these deliverables and submit our application in September, 2026.

Public health relevance
Project Narrative Patients with advanced cancer experience a high prevalence of cancer-related cognitive impairment (CRCI) which can worsen symptomatic toxicities, a key aspect of treatment tolerability. This supplement objectives are to: 1) identify and finalize key research team members, cores, and infrastructure, 2) conduct preliminary research to finalize an integrated biological model related to CRCI and interventions, and 3) finalize an overarching theoretical framework, synergy, and research projects.